MOLECULAR MECHANICAL FORCE FIELD DEVELOPMENT &SUPPORT

A second generation molecular mechanical force field has been developed for use with the AMBER program. This force field is optimized for and is meant to be applied to systems that include explicit solvent, unlike the Weiner et al. force field (1984/1986) which was optimized for gas phase calculations. The Weiner force field has been quite popular, receiving upwards of 300 citations per year in the literature and it is hoped that the new force field will be equally well accepted. One reason for the popularity of these force fields is that they are available for using with the AMBER program which can be obtained by academic researchers at a nominal cost. It is, therefore, quite important that the funding agencies support such work so that there exists an alternative to the much costlier commercial variants of these molecular dynamics programs. Resources of the Computer Graphics Laboratory have been used for visualizing molecules which have been used in the parameterization process. Although the force field has been published, work is still being carried out to expand and test it.